An Investigation of Mental, Physical, and Sleep Health: The Role of Social Determinants

An Investigation of Mental, Physical, and Sleep Health: The Role of Social Determinants
Summary
Sleep deficiency is an important public health concern and is known to significantly impact
mental and physical health. Sleep deficiency is an essential risk factor and marker for
chronic conditions that disproportionately affect racial/ethnic minority populations and further contribute to health
disparities. Social determinants of health are considered a system of schemes providing an understanding of how health
is socially patterned, investigating causal pathways between social conditions and human health and disease.
Noticeably, sleep deficiencies seem to share similar determinants and causal pathways observed for health outcomes
with well-known health disparities. Limited studies have investigated whether social-environmental mechanisms and
pathways that result in health disparities for mental and physical health outcomes can explain sleep deficiencies. This
study will investigate the relative contribution of social-environmental factors at the individual (e.g., biological
vulnerability to elevated blood pressure), interpersonal (e.g., city stress), community (e.g., neighborhood
characteristics), and societal (e.g., societal structure, discrimination) levels and their influence as mechanisms to
understand sleep deficiencies impact on mental and physical health, thus enabling us to substantiate key drivers of
health disparities for racial/ethnic minorities. An understanding of the critical role of sleep deficiencies at the interplay
of upstream social-environmental influences and downstream mental and physical health outcomes will be instrumental
in moving the field toward a more useful integration of behavioral, biological, physiological, and socio-environmental
understanding, which may lead to culturally tailored interventions to reduce the societal burden of health disparities.

Public health relevance
PROJECT NARRATIVE Health disparities among underserved populations are multifactorial, and it is now recognized that disparities in sleep health in addition to social determinants of health are important contributors. This study seeks to understand the intersection of these relationships on functional outcomes. The results of this study will further substantiate key drivers of sleep disparities for racial/ethnic minorities to reduce health disparities and advance health equities.